RECONSTRUCTION OF ACUTELY RUPTURED ANTERIOR CRUCIATE LIGAMENT

A prospective, randomized follow-up study comparing the efficacy of a patel r tendon autograft to a hamstring tendon autograft for reconstruction of the acutely ruptured anterior cruciate ligament deficient knee.